RFA-CE-23-006, Pediatric Trauma Centers RE-AIM at Gun Safety

PROJECT SUMMARY
Universal firearm injury and violence prevention counseling of parents and patients has been recommended by
multiple national organizations for over a decade, yet clinicians rarely deliver this counseling. Barriers to its
implementation must be addressed in order to effectively deliver firearm related injury prevention efforts. The
research team has demonstrated success in the implementation and sustainability of alcohol screening, brief
intervention and referral to treatment protocols in two federally funded multi-site trials at pediatric trauma
centers. The team also has expertise in clinically-based strategies for firearm injury prevention and educational
program development. We will apply our implementation science and subject matter expertise to implement a
universal firearm injury prevention initiative within a national cohort of three pediatric trauma centers with which
we have previously collaborated on multisite research. Our long-term goal is to demonstrate best practices for
pediatric trauma center-based firearm injury prevention strategies that promote safe storage practices and
reduce firearm related injury and death. This proposal, submitted in response to RFA-CE-23-006 funding
option B, will test the effectiveness of a comprehensive training strategy for improving the implementation of a
universal firearm injury prevention effort, ACTFAST (Adopting Comprehensive Training for FireArm Safety in
Trauma centers), through the following primary aims: 1) increase the adoption, implementation and
sustainability of a universal firearm injury prevention initiative within participating pediatric level 1 trauma
centers; 2) increase firearm safety knowledge, attitudes and safe firearm storage practices among parents of
pediatric trauma patients treated within participating pediatric level 1 trauma centers, and through the following
secondary aims: 1) increase trauma center clinicians’ firearm safety knowledge and confidence in delivering a
firearm safety intervention; 2) increase firearm safety knowledge, attitudes and firearm safety practices of
adolescent trauma patients (11-17 years) within participating pediatric level 1 trauma centers. Using the RE-
AIM methodology, we will evaluate our comprehensive strategy across the domains of adoption,
implementation, and maintenance at the institutional level. We will measure clinician firearm safety knowledge
and confidence in delivering firearm prevention counseling after participation in the clinician training program
as measured by pre and post training surveys. In addition, we will collect and analyze parent (n=560) and
adolescent patient (n=280) data before and after ACTFAST implementation for changes in knowledge,
attitudes and, most importantly, practices at baseline and at 2 weeks and 3 months after hospital discharge.

Public health relevance
PROJECT NARRATIVE The proposed study will test the effectiveness of a comprehensive training strategy for the implementation of a universal pediatric-focused firearm injury prevention initiative. Findings will help to establish best practices for delivering firearm injury prevention screening and counseling within the pediatric trauma center. Importantly, this research has the potential to impact clinical care, prevent firearm-related injury and death, and significantly contribute to implementation science.